Mechanism Underlying the Transduction of Epimutations from the Soma to the Male Germline

Project Summary
Most of the studies on epigenetic inheritance focus on the identification of sperm-borne factors that carry
the epigenetic memory and how they act on the epigenome/genome of the embryos so that the specific
epigenetic memory can be recalled and manifested as a specific phenotype in offspring. However, one
fundamental question remains unanswered: given that the effects of exposures, either environmental or
dietary, are presumably initially manifested as epigenetic changes in directly exposed somatic cells (e.g.
pancreatic islet cells, adipocytes, hepatocytes, etc.), how do the phenotype-specific epimutations in
somatic cells get transduced into spermatozoa? Using a highly reproducible mouse model for
intergenerational epigenetic inheritance of a high fat diet (HFD)-induced metabolic disorders, we here
propose a series of experiments to tackle this critical question. Our central hypothesis is that HFD-
induced epimutations in somatic cells can lead to production of specific sncRNAs that are either
encapsulated in extracellular vesicles (EVs), or present as mobile RNAs, which act as the carrier of
epigenetic memory once internalized by spermatozoa through either 1) the intra-testicular mechanism
(i.e., Sertoli cell HDF-specific epigenetic information transmitted to all developing male germ cells or
directly to spermatozoa during spermatogenesis in the testis), or 2) the post-testicular pathway (i.e.,
HFD-specific epigenetic information transmitted from male reproductive tract epithelial cells to
spermatozoa), or 3) a combination of both. To test our hypothesis, we propose to identify when and
where male germ cells gain the ability to transmit the HDF-induced metabolic disorder phenotype (Aim1),
to study how the intra-testicular pathway contributes to the HFD-specific sperm epigenome (Aim2), to
study how the post-testicular pathway influences HFD-specific sperm epigenome (Aim3). Data to be
obtained will help fill the knowledge gap in our understanding of the molecular mechanisms underlying
the intergenerational epigenetic inheritance of paternally acquired traits in general.

Public health relevance
Project Narrative This study aims to uncover the potential hidden pathways for epigenetic information to flow from somatic cells to male germ cells and sperm and thus, become heritable. Data to be obtained will fill the knowledge gap in our understanding of the molecular mechanism underlying the intergenerational epigenetic inheritance of paternally acquired traits in general.